Boxer Training Program in Hematology

Project Summary/Abstract
The Boxer Training Program in Hematology has a strong track record in preparing physicians and
postdoctoral scientists for independent, research-oriented careers in hematology. This is due to a combination
of our rigorous training environment and robust mentorship in hematology research. This program draws on the
research interests and expertise of 41 well-funded faculty members in the University of Michigan Medical School
Departments of Pediatrics, Internal Medicine, Pathology, Surgery, Pharmacology, Cell and Developmental
Biology, Molecular and Integrative Physiology, Biological Chemistry, Anesthesiology, Physical Medicine,
Learning Health Sciences, as well as the Life Sciences Institute, Howard Hughes Medical Institute, Institute for
Social Research, and the Schools of Engineering, Pharmacy, Public Health, and Social Work. Active areas
include molecular, cellular, translational, and clinical research of: 1) the pathophysiology of the immune system;
2) normal and malignant hematopoiesis; 3) hemostasis, thrombosis, and vascular biology; 4) blood and marrow
transplantation; and 5) erythrocyte physiology and disease. A Selection and Monitoring Committee will recruit
MD, MD/PhD, and PhD trainees with strong academic credentials who desire a scholarly career encompassing
hematology research and teaching. MD candidates will have had 3 years of house officer training in Pediatrics
or Internal Medicine and a year of clinical training in Pediatric or Adult Hematology/Oncology. PhD candidates
will have a major interest in hematology-related research. Six trainees per year will commit a minimum of 2
years under supervision of a faculty mentor, developing expertise in posing feasible scientific questions,
acquiring skills to answer these questions, and critically evaluating data obtained. During their research training,
trainees are continuously mentored and evaluated semiannually by a Mentoring Committee. Trainees present
the results of their investigations, participate in discussions of data obtained by their colleagues, and attend
relevant research seminars and interact with faculty members in basic, translational, and clinical sciences. In
addition, the program will annually provide two, short-term training opportunities for medical students to
participate in mentored research for a 12-week period. This will offer the opportunity to develop interest in
hematology and enhance the pipeline for students. The Boxer Training Program provides a detailed strategy
for recruitment and training of diverse and underrepresented individuals, as well as delivering oversight through
individualized development plans and advisory committees. Overall, this program will fulfill a critical need to train
the next generation of academic hematologists who will bridge the gap between laboratory and clinical research.

Public health relevance
Project Narrative Hematologic diseases affect millions of individuals throughout the United States. The goal of this program is to train the next generation of investigators in academic hematology who will develop new diagnostics and therapeutics for patients with these disorders.